Driving tissue formation by inductive stem cell sheet technology

DESCRIPTION (provided by applicant): Osteoarthritis (OA) is a degenerative disease of articular cartilage affecting millions of people worldwide, including over 70% of people over 65. When articular cartilage is damaged, it has inadequate intrinsic ability to repair itself due to it low cellularity and avascular nature. Current techniques do not typically restore total function, and thus an alternative therapy is needed. Tissue engineering of cartilage tissue has great potential as a viable technology to meet this need. Human mesenchymal stem cells (hMSCs) from bone marrow are a promising, clinically relevant cell source for these cartilage tissue engineering strategies. Two important factors for the in vitro chondrogenic induction of hMSCs are high initial cell density and exposure to transforming growth factor-β (TGF-β). We have engineered a system of self-assembling hMSC sheets incorporated with growth factor releasing hydrogel microspheres. Gelatin is used as the base biomaterial for the microspheres, as it forms biocompatible, biodegradable hydrogels that can facilitate the controlled delivery of TGF-β1 over time in the presence of cell-secreted proteases while preserving bioactivity of the growth factor. This system of self-assembled, microsphere-incorporated hMSC sheets is capable of forming cartilage in the presence of exogenous TGF-β1 or with TGF-β1 released from the incorporated microspheres. The incorporation of TGF-β1 loaded microspheres could eliminate the need for exogenous growth factor supplementation, overcome transport limitations of exogenous supplementation, decrease culture time necessary prior to implantation of neocartilage constructs, and circumvent the problem of los of the chondrogenic phenotype in vivo by providing prolonged local exposure of hMSCs to chondrogenic growth factor. In addition, dynamic compression and perfusion of tissue engineered cartilage sheets have been shown to improve the mechanical properties and increase extracellular matrix synthesis of resulting tissue. Our central hypothesis is that the chondrogenic potential of these hMSC-microsphere sheets can be regulated by controlling growth factor presentation to the cells in the presence or absence of mechanical loading and perfusion. The Specific Aims are: (1) Determine the role of spatial and temporal presentation of chondrogenic factors and cell number on hMSC sheet chondrogenesis; (2) Determine the effects of dynamic compressive mechanical loading and perfusion, separately and in combination, of the hMSC sheet system on cartilage matrix composition and organization and resulting construct mechanical properties; and (3) Examine the capacity of this hMSC sheet system to repair articular cartilage in a full-thickness critical-sized cartilage defect in a rabbit model. The successful completion of the proposed work will provide the basis for a clinically relevant tissue engineering strategy for the repair of damaged articular cartilage.

Public health relevance
PUBLIC HEALTH RELEVANCE: Damaged articular cartilage, which is an avascular tissue with few cells, does not have an intrinsic capacity to repair itself. We propose to engineer chondrogenic human mesenchymal stem cell (hMSC) sheets containing growth factor-laden microspheres to form cartilage and to demonstrate their potential in healing full thickness articular cartilage defects in vivo. The successful execution of the proposed work will provide the basis for a clinically relevant tissue engineering strategy for the regeneration of damaged articular cartilage, which would be a powerful technology for advancing the treatment of patients suffering from cartilage loss or damage as is present in osteoarthritis. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Rationale: Osteoarthritis (OA) is a degenerative disease of articular cartilage affecting millions of people worldwide. Damaged articular cartilage, which is an avascular tissue with few cells, does not have an intrinsic ability to repair itself. Current treatments do not typically restore total function, and thus an alternative therapy is needed. Tissue engineering of cartilage tissue has great potential as a viable technology to meet this need. Mesenchymal stem cells (MSCs) from bone marrow are a promising cell source for cartilage tissue engineering strategies, as they can be expanded in culture without losing multipotency, and can be guided to differentiate into many cell types including chondrocytes. Specifically, two important factors for the in vitro chondrogenic induction of MSCs are high initial cell density and exposure to transforming growth factor-β (TGF-β). Several in vitro culture methods have been developed for MSC chondrogenesis, including aggregate or pelet culture, micromass culture, and self-assembling cell sheet systems1-9. In particular, self-assembling cell sheets show promise for use in cartilage tissue engineering applications as they may form larger constructs with much greater surface areas and volumes. Innovation: We have engineered a system of self-assembling human MSC (hMSC) sheets incorporated with growth factor releasing, genipin crosslinked gelatin hydrogel microspheres. Gelatin is a biocompatible, biodegradable hydrogel that has been demonstrated to facilitate the controlled delivery of TGF-β1 over time in the presence of cell-secreted proteases while preserving bioactivity of the growth factor10,11. The incorporation of biodegradable gelatin microspheres within MSC sheets improves the mechanical properties of the sheets, both before and after the microspheres have degraded. This system of self-assembled, microsphere- incorporated hMSC sheets is capable of forming cartilage in the presence of exogenous TGF-β1 or with TGF- β1 released from the incorporated microspheres. Incorporating microspheres with controlled release of chondrogenic growth factor within the hMSC sheets permits regulation over its spatial and temporal presentation to cells in the construct. Beyond producing sheets with superior mechanical properties and more uniform matrix deposition, there may be further advantages of using growth factor-releasing microspheres for in vivo implantation. By eliminating the need for exogenous growth factor supplementation, incorporation of TGF-β1 loaded microspheres could decrease the amount of growth factor required, decrease the culture time necessary prior to implantation of neocartilage constructs and provide prolonged local exposure of hMSCs to chondrogenic growth factor in vivo. The goal of the proposed work is to engineer these chondrogenic hMSC sheets containing growth factor- laden microspheres to improve the quality and quantity of cartilage formed and to demonstrate their promise in repairing full thickness articular cartilage defects in vivo. Our hypothesis is that the chondrogenic potential of these hMSC-microsphere sheets can be regulated by controlling growth factor presentation to the cells in the presence or absence of mechanical loading and perfusion. The impact of these important variables on chondrogenesis of the hMSCs and subsequent tissue formation will be identified. The capacity of these chondrogenic hMSC sheets to be readily implanted to heal ful thicknes articular cartilage defects without extensive in vitro culture will then be examined. The following specific aims will address the hypothesis: Aim 1 - Determine the role of spatial and temporal presentation of chondrogenic factors and cell number on hMSC sheet chondrogenesis. We have shown that hMSC sheets with incorporated TGF-β1- laden gelatin microspheres undergo chondrogenesis. The goal of this Aim is to examine the effect varying the spatial distribution of the chondrogenic growth factor-laden microspheres, the concentration of growth factor in the microspheres, the release profile of that growth factor, and the number of hMSCs incorporated into the constructs has on the chondrogenesis of the hMSC sheets and subsequent cartilage formation. Aim 2 - Determine the effects of dynamic compressive mechanical loading and perfusion, separately and in combination, of the hMSC sheet system on cartilage matrix composition and organization and resulting construct mechanical properties. Studies sugest that perfusion and dynamic unconfined compression improve the mechanical properties and matrix synthesis in other cartilage tissue engineering approaches12-17. Therefore, to elucidate the efects of these variables in this new hMSC-microsphere sheet system, the shets will be subjected to perfusion and/or dynamic compressive mechanical loading to determine their role in the resulting cartilage sheet biochemical and functional properties. Aim 3 - Examine the capacity of this hMSC sheet system to repair articular cartilage in a full thickness critical-sized cartilage defect in a rabbit model. The hMSC-microsphere sheets will be implanted into full thickness articular cartilage defects to quantitatively and qualitatively determine their ability to heal the cartilage tissue. These in vivo results will provide strong evidence demonstrating the system's potential clinical utility. Significance: The successful execution of the proposed work will provide a clinically relevant tissue engineering strategy for the repair of damaged articular cartilage. This would be a very powerful technology for advancing the treatment of patients suffering from cartilage loss or damage such as is present in osteoarthritis.